Identification of Veterans at-risk for Suicide: a Multidisciplinary Approach

Even the strongest of individual risk factors are poor predictors of suicide attempts. Many risk factors rely on
subjective or self-­reported measures and underreporting contributes to poor prediction accuracy. In the midst
of the ongoing Veteran suicide crisis, we clearly need new, objective predictors of risk that can be implemented
across the VA system. Previous findings indicate that behavioral and neuroimaging correlates of decision-­
making and cognitive control are promising, objective markers of suicidal risk. Though intriguing, these findings
are from research conducted primarily in depressed civilians. It is unknown if these potential markers of suicide
risk will generalize to a transdiagnostic sample of Veterans. The primary research objective of this CDA-­2 is to
evaluate whether structural neuroimaging, and functional neuroimaging during decision-­making and cognitive
control tasks can be used to identify brain-­behavior correlates of suicidal thoughts and behaviors in Veterans.
Suicidal thoughts and behaviors are associated with short-­sighted, maladaptive, decision-­making that is
accompanied by differences in striatal-­prefrontal reward circuitry. However, studies that have compared
decision-­making task performance between individuals who have made more organized, lethal attempts at
self-­harm vs. those making less serious attempts have identified differences in their behavior that may supply
more nuanced information about suicidal severity. Interestingly, the decision-­making of serious attempters is
actually less impulsive. In fact, decision making in serious attempters is less impulsive even relative to healthy
controls. This implies that a greater capacity for cognitive control may facilitate, rather than protect against,
harm in suicidal individuals. These potential objective markers of suicidal thoughts and behaviors and suicidal
risk severity are promising and demand further evaluation. The proposed behavioral and neuroimaging
methodologies (diffusion imaging, morphometry analyses, univariate and functional connectivity neuroimaging)
included in this proposal have been successfully applied by the candidate, a cognitive neuroscientist, in
previous published work. The candidate’s exploratory research objective is to apply machine learning
algorithms to a blended dataset of participants’ electronic health data and neurocognitive markers in a
preliminary predictive modeling project. This exploratory objective will provide foundational data for future
Merit-­funded work focused on the development of clinically implementable suicide risk prediction tools. Though
the proposed neurocognitive research has the potential to improve the effectiveness of suicide screening and
treatment, the candidate acknowledges that all too often, insights from neuroscience fail to improve clinical
care because few neuroscientists have the clinical perspective needed to translate mechanistic knowledge into
clinical innovations. The protected time funded by this CDA award will allow the candidate to participate in
activities imparting a unique combination of skills and perspectives that will allow the candidate to bridge basic
and clinical science in the service of reducing Veteran suicide. The CDA training plan builds competencies in
three areas: 1) methodologies and practical skills for suicide research, 2) psychiatric assessment and clinical
perspective, and 3) training in bioinformatics and machine learning methodologies. The candidate is well-­
established within the VA system holding a Health Science Specialist position since 2015. The candidate’s
mentorship team is comprised primarily of VA clinician-­scientists actively working with suicidal or high-­risk
populations and are well-­qualified to mentor the candidate toward the career goal of becoming a leader in
translational Veteran suicide research.

Public health relevance
Recent Veterans are now more likely to die by suicide than combat. The proposed CDA- 2 research will generate novel biological and behavioral makers of suicide risk, and will conduct a preliminary demonstration of their use in predictive models of suicidal thoughts and behaviors. Methods used to define risk factors are implemented in a transdiagnostic Veteran sample. Importantly, defining risk factors independent of psychiatric population will increase generalizability of study findings to a wider Veteran population. These novel suicide risk factors will identify high- risk Veterans that may not have been identified by traditional suicide assessment methods. This means that more Veterans at risk for suicide will receive life- saving interventions, thus, this research is consistent with the VA’s mission to combat Veteran suicide.